Diversity Supplement: BCM Center for Precision Medicine Models

ABSTRACT
Recent studies have reported that genetic disruptions of the kynurenine pathway (KP) are a cause of
congenital nicotinamide adenine dinucleotide (NAD) deficiencies in families with a history of birth defects and
recurrent miscarriages. Mammals synthesize NAD+ from two different pathways. The KP biosynthesizes NAD+
de novo from dietary tryptophan, whereas the Preiss-Handler pathway utilizes dietary niacin. Birth defects
associated with KP disruptions include phenotypes of vertebral, anal, cardiac, tracheoesophageal, renal, and
limb anomalies; some patients have developmental delay, learning disorders, autism, and/or microcephaly.
Through the Undiagnosed Diseases Network site at Baylor College of Medicine (BCM), we have identified a
patient with biallelic variants in the kynurenine 3-monooxygenase (KMO) gene, which encodes a key enzyme
in the KP. The patient has congenital anomalies, short stature, and neurocognitive delays, representing a novel
congenital NAD deficiency disorder (CNDD). In addition, she has extreme elevations in the serum levels of
upstream metabolites (kynurenine and kynurenate). Dysregulation of these same metabolites have previously
been linked to neuropsychiatric phenotypes in human patients with no obvious inborn errors of metabolism.
Therefore, we hypothesize that KMO deficiency, a novel congenital NAD deficiency disorder, increases
the risk for congenital anomalies and postnatal phenotypes, some of which are preventable with niacin
supplementation. The Baylor College of Medicine (BCM) Center for Precision Medicine Models generates
precision mouse models to support the discovery of novel undiagnosed disorders like KMO deficiency. These
models serve as resources for additional pre-clinical studies investigating personalized and preventative
medicine approaches to their care. Within the parent grant, we generated Kmo knockout (Kmo-/-) mice to
explore the increased vulnerability of Kmo-/- embryos to congenital anomalies in the setting of low niacin diet.
We will extend the studies in the parent grant to further characterize the prenatal and postnatal phenotypes
associated with KMO deficiency and test whether niacin supplementation prevents the phenotypes. Thus, my
proposed studies will demonstrate that biallelic loss-of-function variants in KMO cause a novel form of CNDD
and demonstrate whether niacin supplementation prenatally or postnatally may prevent phenotypes associated
with this new disorder. These findings will have the potential to benefit individuals with CNDD as well as
provide insights into the role of NAD and kynurenine metabolism in normal prenatal and postnatal
development.

Public health relevance
PROJECT NARRATIVE This project serves to train a PhD student in mouse modeling, mouse phenotyping, and translational research in the area of rare, undiagnosed genetic disorders. We will utilize a mouse model to investigate prenatal and postnatal phenotypes associated with KMO deficiency, a novel disorder of NAD metabolism. We will also evaluate the role of dietary niacin and tryptophan in the severity of these phenotypes in the KMO-deficient mouse.